PROSPECTIVE STUDY ON THE GROWTH AND NUTRITIONAL STATUS OF EB

Observe the growth and nutritional status of those patients with EB who are undergoing gastrostomy (feeding tube) before and after gastrostomy procedure.